Center to Improve Chronic disease Outcomes through Multi-level and Multi-generational approaches Unifying Novel Interventions and Training for health EquitY (The COMMUNITY Center)

PROJECT SUMMARY/ABSTRACT
This project will contribute to reducing health disparities in patients with multiple chronic conditions by expanding
the scope of our Intervention to iMProve AdherenCe equiTably (IMPACT) trial to include patients with metastatic
breast cancer (MBC). The IMPACT trial is currently enrolling patients with early-stage/non-metastatic breast
cancer (BC) to test whether a multicomponent intervention focused on digital and pharmaco-equity improves
adherence to both cardiovascular medications and endocrine therapy (ET) for adjuvant BC treatment. Among
adults with chronic illness, 30% to 50% of medications are not taken as prescribed; medication nonadherence is
particularly prevalent among minorities and is associated with a higher risk of death and hospitalization, and high
healthcare costs. Medication adherence has become a more salient issue in MBC care with the increased
availability and efficacy of novel oral anticancer therapies such as cyclin-dependent kinase 4/6 inhibitors
(CDK4/6i). Furthermore, improvements in MBC survival outcomes have resulted in a growing tail of long-term
MBC survivors at risk for aging-associated cardiovascular disease (CVD). Management of CVD risk factors is
crucial as cardiovascular comorbidities are associated with poor outcomes in patients with MBC. Yet little is
known about the prevalence and drivers of medication nonadherence in patients with MBC and CVD. There is
also a research gap concerning adherence interventions in this patient population, especially interventions
targeting adherence to multiple chronic medications.
Our proposed study will harness the medication nonadherence screening and intervention tools developed
through the IMPACT trial and other components of the COMMUNITY Center to address this research gap. We
will conduct a retrospective cohort study to evaluate the prevalence and correlates of nonadherence to
ET/CDK4/6i and CVD medications in socioeconomically diverse patients with MBC and CVD risk factors, utilizing
EHR-based pharmacy fill/order data. We will also examine medication- and patient-level factors associated with
nonadherence. We will conduct a pilot, single-arm trial of the adherence intervention developed in the parent
IMPACT study (digital training, smartphone provision, pharmacist-led counseling tailored to patient’s adherence
barriers) among 35 patients with MBC and CVD risk factors to evaluate its preliminary efficacy and acceptability
in this population. Finally, we will gain a deeper understanding of the impact of social determinants of health
(SDOH) on medication nonadherence through semi-structured interviews with a subset of participants to our
pilot trial, leveraging the SDOH data collected with the support of a 2023 COMMUNITY Center Investigator
Development Core pilot award. To our knowledge, this will be the first study focused on understanding and
improving global medication adherence among patients with MBC and other chronic conditions. If successful, it
could provide a roadmap for future randomized trials to equitably improve adherence and clinical outcomes in
this population.

Public health relevance
PROJECT NARRATIVE Given dramatic improvements in survival among patients with metastatic breast cancer and the association between cardiovascular risk factors and poor clinical outcomes, focused efforts are needed to improve adherence to both oncological and cardiovascular medications in this patient population, especially among minorities at highest risk for adverse outcomes. We will leverage the screening and intervention tools developed through the Intervention to iMProve AdherenCe equiTably (IMPACT) trial and other components of the COMMUNITY Center to address the research gap concerning adherence to multiple chronic medications in patients with metastatic breast cancer and cardiovascular risk factors. If successful, our study could provide a roadmap for future randomized trials to improve adherence and clinical outcomes in this population and reduce long-standing health disparities.